Mechanisms of Synaptic Protection in Cognitive Resilence to Alzheimer's Disease Neuropathology

PROJECT SUMMARY/ABSTRACT
There is ample scientific evidence that toxic oligomers of A and tau, considered the major neuropathological
factors in Alzheimer’s disease (AD) lead to synaptic failure and dementia, but is also well recognized that some
individuals can accumulate significant AD neuropathology without clinical manifestations. The established
existence of these non-demented with high pathology (NDAN) individuals, suggests that if binding of A
oligomers to specific AMPA and NMDA receptors trigger Ca2+ disruption and synaptic failure in AD, then
modifications in the pharmacology or abundance of these receptors may underlie synaptic protection in NDAN
individuals. However, little is known about the pharmacological sensitivity of human native glutamate receptors
to A and tau oligomers in AD, or their role in resilience, as information primarily has come from studies in animal
models of AD or protein expression systems. Here we will fill in this critical gap of our current knowledge by
identifying the synaptic proteins involved in glutamatergic signaling and Ca2+ dysregulation in AD, evaluating
whether modifications of these proteins correlate with metrics of synaptic preservation in NDAN individuals, and
determining whether A and tau oligomers differentially activate human native synaptic receptors in NDAN
individuals compared to those in AD and controls. The present proposal will test the hypothesis that differences
in the regional abundance of Ca2+-permeable glutamate receptors and/or their pharmacodynamics profile in
response to oligomeric species distinguishes NDAN from AD and control subjects. We will test our hypothesis
in a rigorously characterized cohort of postmortem NDAN, AD, and age-matched normal cognitive control brains,
using two unique and innovative approaches: Microtransplantation of Synaptic Membranes (MSM) to evaluate
receptor electrical activity of native receptors complexes isolated from autopsy human brain, and
Electrophysiologically-anchored Dataset Analysis (EDA) to identify proteins that correlate with receptors’ activity.
The rationale for this project is that determining the pharmacological sensitivity of the natural targets of toxic
oligomers is likely to offer a strong framework whereby novel strategies to AD therapy can be developed. Two
complementary aims are proposed. Aim 1 will identify the impact of gene expression modifications on the
abundance and function of Ca2+ permeable human native glutamate receptors in NDAN compared to AD and
control cases, and aim 2 will evaluate the efficacy of A and tau oligomers to activate human native synaptic
glutamate receptors from NDAN, AD and control cases. At the end of the proposed research we expect to have
defined the mechanisms whereby oligomers trigger synaptic Ca2+ dysregulation in AD but not in NDAN subjects.
These results will lay the foundations for the future development of innovative target-directed pharmacologic
interventions to promote synaptic resilience in AD as a clinically valuable, effective therapeutic approach.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it focuses on identifying previously unknown molecular mechanisms mediating abnormal synaptic communication triggered by soluble oligomers in Alzheimer’s disease, and the modifications of those mechanisms which ultimately promote synaptic protection in people resilient to soluble oligomers effects. This is expected to provide new knowledge about potential targets of pharmacological intervention and drive the development of a novel, effective therapy for AD, thus improving these patients’ health while driving down the societal cost for their care. The proposed research is relevant to the part of NIH’s mission concerned with fostering creative discoveries and their application to advance the Nation’s capacity to protect and improve health.